Assessment of neural tube defects among newborns in Uganda: A study of prevalence, risk factors, and the role of gene-environmental interactions (NTDs in Uganda)

PROJECT SUMMARY
Birth defects impact every organ system with the most common being congenital heart defects closely followed
by neural tube defects (NTDs). NTDs are defined as the group of birth defects that impact either the brain or
spine and are caused by the improper closure of the embryonic neural tube. The commonest types of NTDs are
spina bifida, encephalocele, and anencephaly.5 Globally, about 300,000 to 400,000 babies are born with NTDs
resulting in 88,000 deaths and 8.6 million disability adjusted life years (DALYs) annually with 94% of severe
cases occurring in LMICs. In LMICs, over 1.67/1000 babies born annually have NTDs, and of these 1.13/1000
have spina bifida, 0.25/1000 have anencephaly, and 0.15/1000 have encephalocele. Despite the importance of
NTDs, 61.9% (120/194) of the World Health Organization (WHO) member countries lack data on NTDs and
therefore the reported figures of NTDs may even be higher. In Africa, where most of the Sub-Saharan countries
are LMICs, the prevalence of NTDs is reported to be 1.2/1000 live births and of these 0.49/1000 have spina
bifida, 0.23/1000 have anencephaly, and 0.17/1000 have encephalocele. In Uganda, the burden of NTDs has
continued to be a serious public health challenge, though there is limited updated data. There are several risk
factors that have been postulated to lead to the increased prevalence of NTDs though the definitive cause is still
unknown. A combination of various factors has been reported that may involve environmental-gene interactions
during neural tube development. To date, there is a paucity of information about the role of the reported risk
factors and the mutations or alterations in morphology or functions of specific genes, receptors, and enzymes
responsible for folic acid metabolism in African NTD samples. Therefore, the main objective of the current study
is to determine the association between relevant risk factors and NTDs and their influence on the reported genes
and receptors. Our primary study design is a prospective case-control study. We will recruit 98 NTD newborns
and their mothers along with our matched control of 98 newborns and their mothers without NTDs from the cross-
sectional sample detailed above. We will assess demographic, socioeconomic, family history, infectious
exposures, medications, herbal use, environmental chemical exposure, nutritional deficiencies, and food
consumption patterns using a structured questionnaire. We will also take blood samples from newborns and their
mothers to determine the blood levels of aflatoxins, fumonisins, and ochratoxins; blood levels of folic acid and
active 5-MTHF metabolite; and genetic variation in hFRα, MTHFR, and CELSR genes. Findings from our study
will help inform NTDs management practices and policies in Uganda and set the stage for future NTDs prevention
and intervention studies.

Public health relevance
PROJECT NARRATIVE Birth defects, inclusive of neural tube defects (NTDs), occur in over 8 million newborns globally, of which 3.3 million die annually before their fifth birthday, and more than 90% of these deaths occur in resource-limited countries. Unfortunately, reliable epidemiologic data on NTDs in low-resource settings is limited; thus, we will examine the prevalence, risk factors, and role of gene-environmental interactions in Uganda. Findings from our study will help inform NTDs management practices and policies in Uganda and set the stage for future NTDs prevention and intervention studies.